Neuromodulatory strategies targeting cortical and spinal pathways to facilitate paretic leg motor control during walking in individuals with stroke

Project Summary/Abstract
This project aims to: (Aim 1) determine the effects of transcutaneous spinal cord stimulation (SCS) with
constraint force to the non-paretic leg during treadmill walking on paretic leg motor control in individuals with
stroke; and (Aim 2) determine the combined effects of transcutaneous SCS and non-invasive brain stimulation
(NIBS) with constraint force to the non-paretic leg during treadmill walking on paretic leg motor control in
individuals with stroke. After a stroke, individuals often rely on their non-paretic leg during walking,
compensating for the impaired motor control and muscle weakness in the paretic leg. Current gait training
approaches after stroke, such as treadmill training, have shown immediate benefits on walking function, yet
more than 50% of stroke patients still struggle with impaired walking post-treatment. This persistent difficulty in
walking may be attributed, at least in part, to the repetitive use of the compensatory strategies. Such strategies
can further exacerbate the motor impairment of the paretic leg, contributing to greater gait asymmetry and
higher risk of falls. Therefore, there is a critical need to develop gait interventions targeting paretic leg motor
control during walking after stroke. Previously, we found that the application of constraint force to the non-
paretic leg during treadmill walking facilitates the use of the paretic leg in individuals post-stroke. In this
proposal, we aim to utilize non-invasive neuromodulatory approaches during this constraint force induced gait
training to further enhance paretic leg motor control during walking post-stroke. Our preliminary results suggest
that combining transcutaneous SCS with the application of constraint force to the non-paretic leg during
treadmill walking facilitates greater step length, stance time, step height, muscle activity, and propulsive force
of the paretic leg compared to constraint force induced gait training alone (Aim 1). We also propose that
transcranial direct current stimulation (tDCS) combined with SCS during gait training may provide further
improvements. One of the popular views into the mechanism of SCS is that stimulation increases excitability of
the spinal circuits and modulates the responsiveness to corticospinal inputs. Given that individuals post-stroke
demonstrate reduced descending cortical drive due to damaged corticospinal tract (CST), it is possible that the
addition of tDCS, to upregulate the CST inputs, enhances the effectiveness of SCS which may further improve
paretic leg motor control during walking. Results from this proposal may provide valuable insights to develop
effective gait rehabilitation strategies to optimize walking recovery in individuals with stroke.

Public health relevance
Project Narrative Long-term walking impairments after stroke reduce community involvement, ability to perform activities of daily living, health status, and quality of life. The proposed work will provide a scientific foundation for developing an effective gait intervention by incorporating targeted neuromodulatory strategies to enhance paretic leg motor control during walking after stroke. These results will help optimize rehabilitation strategies for improving walking, thereby improving community ambulation and quality of life after stroke while reducing healthcare burden.